IGF::OT::IGF PRODUCTION OF 600 BOTTLES OF TETRAHYDROURIDINE POWDER

The Contractor will fill six hundred (600) containers with three grams (3g) of Tetrahydrouridine (THU) powder into each suitable size screw cap HDPE container, label them, and conduct weight variation and chemical ID tests as QC release. The product will then be sent to the Clinical repository and Shelf-life Contractor.